Regulation of Alternative Splicing in the Brain by a Large Assembly of Splicing Regulators

PROJECT SUMMARY/ABSTRACT
Alternative splicing is a key process in shaping the functional complexity of the brain. Accordingly, many
neurologic and psychiatric disorders are caused by mutations in RNA binding proteins or their targets in
alternative splicing. The Rbfox family of RNA Binding proteins regulate alternative splicing during neuronal
development and their mutations have been implicated in autism spectrum disorder and various familial
epileptic disorders. To understand the role of Rbfox in these diseases, many studies have focused on how
individual Rbfox proteins bind to their targets and regulate their splicing. However, Rbfox proteins are also
known to interact with cofactors that influence their function. We previously found that nuclear Rbfox proteins in
the mouse brain are almost exclusively bound to a large assembly of splicing regulators (LASR). However, it
remains unknown what the full subunits of the neuronal LASR complex are and how they interact with Rbfox to
regulate alternative splicing in neurons. In this proposal, I will define the neuronal components of LASR,
determine the transcriptome-wide targets of the LASR/Rbfox complex and its subunits in the mouse brain, and
analyze how components of LASR affect Rbfox’s splicing regulatory activity in neurons. These studies will
elucidate how combinatorial interactions between RNA binding proteins in a novel splicing regulatory protein
complex shape the gene regulatory circuit of the brain and will further our understanding of the function of the
Rbfox proteins which have been implicated in epilepsy and autism spectrum disorder.

Public health relevance
PROJECT NARRATIVE Many neurological and psychiatric disorders are caused by mutations in splicing regulators or their targets in alternative splicing. However, we are unable to treat many of these diseases due to a lack of understanding of how these regulators shape the neuronal alternative splicing network. This project will provide one of the first integrated biochemical and genome-wide studies of a multi-subunit complex of splicing regulators found in the brain and can advance our understanding of the gene regulatory circuit underlying neurological and psychiatric disease.